Enrichment Program

OVERVIEW. The Enrichment Program seeks to accomplish the goals of the Liver Center in four related ways. First, the Program provides Center members with the latest information about their specific areas of interest. Second, the Program seeks to broaden the appreciation that Center members have for related areas of research in liver biology and pathobiology. Third, the Program seeks to enhance collaboration among Center members; In part because of the enrichment program, nearly all Center members collaborate with at least one other Center member (Illustration IV) and 50% of all Center-related publications are co-authored by multiple Center members (Illustration VII). Finally, the Program serves as an outreach mechanism to non-liver physicians, scientists and lay people to enhance their understanding of liver disease. We have established several mechanisms to achieve these goals. This includes a regular seminar series, a bi-annual retreat, a newsletter, and certain special educational programs. All Center seminars, conferences and symposia are posted on the Center's website and advertised via poster and e-mail notification.